Data Management and Storage System for Shared Resource Facilities

Data Management and Storage System for Shared Resource Facilities Project Summary Past investments from the NIH, including the Delaware INBRE and several COBRE center grants, have helped to catalyze biomedical and other life science research in Delaware through establishment of a network of Shared Resource Facilities (SRFs). Several of these SRFs centrally housed at the Delaware Biotechnology Institute (DBI), provide services in Bio-imaging, Genomics, Bioinformatics, and High Performance Computing. These facilities have collectively supported over 1000 researchers across UD and our network of six academic and biomedical research partners in Delaware over the past three years, having a significant impact on biomedical research statewide. With significant advances in instrumentation, including high-resolution, multi-dimensional bioimaging approaches and high-throughput massively parallel DNA sequencing platforms, raw data production from our SRFs has increased significantly in recent years. Processing and analysis further compound the size of these data and require access to significant high-performance computational infrastructure. An advanced and scalable data management solution is crucial to allow our SRFs to meet the data demands of the instrumentation and provide the services that our user-base needs to accomplish their research goals, while maintaining compliance with applicable data integrity, security, and archiving requirements. This proposal would build a centralized data management and processing infrastructure to meet the needs of our SRFs. We request a Dell EMC Isilon storage cluster with integrated data management solution, providing 2 petabytes of raw capacity configured to provide 357TB of fast storage for live data analysis and 832TB of dual redundancy storage for intermediate term data archiving. This solution would meet our projected needs, but is also easily scalable providing the ability to meet other needs that may arise. The platform allows for flexible data access protocols that can be adapted to the varied use-cases our SRFs each represent. The proposed system would allow for a higher level of automation, streamlining and simplifying data management, increasing the efficiency of our operations, while providing new capabilities for provenance tracking and data security. By supporting the data management, storage, and primary data analysis needs of our SRFs, this investment will enable the advancement of research for hundreds of biomedical and life scientists in Delaware.

Public health relevance
Project Narrative The University of Delaware (UD) requests a Data Management Infrastructure to handle the growing needs of its Shared Resource Facilities (SRFs) supporting biomedical and life science research. These SRFs have been developed and supported through NIH support including through the Delaware INBRE and various COBRE programs, and enable researchers across UD and its statewide network of partner institutions to utilize state-of-the-art bioimaging, genomics, bioinformatics, and high performance computational instrumentation and expertise to advance their research. The increasingly storage-intensive nature of these data require an advanced management solution that will provide the data storage, security, and reliability needed to allow our facilities to continue offering the instrumentation and services needed in the coming years to empower hundreds of biomedical and life science researchers.